Lifecourse Residential Segregation, Ethnic Enclaves and Risk and Resilience to ADRD in Diverse Cohorts

PROJECT SUMMARY (ABSTRACT)
As the population ages, the prevalence and risk for Alzheimer’s disease and related dementia
(ADRD) is expected to increase with even greater risk for Blacks and Hispanic/Latinx groups. Historical
and contemporary structural racism in the form of residential segregation is a fundamental cause of health
disparities that may contribute to ADRD inequities. However, residential segregation in some communities
may inadvertently lead to formation of ethnic enclaves where higher concentration and proportion of some
ethnic groups may be protective against the negative effects of segregation. Some studies found that
higher residential segregation is associated with greater cognitive decline and higher risk for ADRD, but
other found that it may be protective. It is unclear how lifecourse residential segregation is associated with
cognitive decline and risk for ADRD. This project will determine the relationship of lifecourse
residential segregation with ADRD using measures of incident ADRD, cognition and neuroimaging
brain biomarkers. Furthermore, we will explore how education and poverty rates may mediate the
relationship of segregation and ADRD risk.
We will use data from the KHANDLE and STAR cohort studies, two longitudinal cohort studies of
racial/ethnically diverse participants of older-adults residing in the Northern California area. Measures of
residential segregation indices of evenness, exposure, concentration, centralization, and clustering will be
derived from decennial census data from 1970s to 2010s and linked with historical addresses of
participants across 7 timepoints (birth, ages 5, 10, 18, 30, 40, 65). Causal inferences models will be used
to (Aim 1) examine the association of lifecourse residential segregation and cognition for approximately
2476 participants and (Aim 3) examine 614 subset of participants with MRI markers of brain health.
Mediation analysis (Aim 2) will be conducted for educational quality and attainment, and poverty rates to
assess the impact of proximal and distal social determinants of health on the relationship between
residential segregation and late-life cognition.
As of current, this is the first study to our knowledge that will examine the lifecourse timing and
duration of residential segregation with cognitive decline and risk for ADRD in multiple racial groups. This
study present opportunities to comprehensively assess the effects of lifecourse residential segregation,
significantly improving our understanding of structural racism on late-life cognitive outcomes and ADRD.
Findings from this study may inform decision-making policies on equitable home lending, and
neighborhood reform for healthy cognitive aging. With the support of an exemplary team of experts, the
applicant will be trained and enhanced with skills, research proficiency, and rigorous methodology needed
to carry out this project and advanced his career as a researcher on health disparities.

Public health relevance
PROJECT NARRATIVE The proposed project will identify the relationship of historical and contemporary residential segregation on cognitive aging and Alzheimer’s disease and related dementia in older adults. The project will provide insights on the role of education and poverty rates on the relationships between residential segregation and late-life cognitive decline and risk of Alzheimer’s disease and related dementia. Lastly, we will explore this relationship using neuroimaging biomarkers of hippocampal and whitter matter hyperintensities volume.